Administrative and Research Support Core

Abstract – Administrative (Admin) Core – Core A
This renewal application of the Hopkins’ Economics of Alzheimer’s Disease & Services (HEADS) Center
builds on notable successes of our first project period in which we established an interdisciplinary research
community, developed research resources and data infrastructure, and formalized partnerships to address
major evidence gaps in our understanding of ADRD care and its consequences. In the next project period,
we will expand our Center activities through 5 Cores, launch a new Emerging Scholars Mentorship Program,
enhance community with enriched internal and external communications, engage in new real-world
translation activities, assemble a Lived Experience Panel and Shared Care Research Network, and expand
our research resources through innovative data assets and infrastructure. The Administrative and Research
Support (Admin) Core is central to the success of these initiatives by advancing the Center’s overall aims
efficiently and effectively with an emphasis on management, planning, and oversight as well as attention to
strategy and values. The Admin Core will build on its successes with the following Specific Aims.
AIM 1 provides overall scientific, strategic, and programmatic leadership to the Center. We accomplish Aim 1
by: 1) Supporting our Center’s organizational and governance structure, 2) Coordinating, facilitating, and
monitoring day-to-day HEADS activities through our Center Executive Committee, 3) Strategic planning
to harness strengths, overcome challenges, and identify opportunities with the Executive Committee,
External Advisory Board (EAB), and Senior Advisors; and 4) Fostering research community through
stimulating dialogue, collaborations, and knowledge sharing among Affiliates including a monthly
Seminar Series. AIM 2 centrally manages and tracks Center activities, accomplishments, and resources.
We accomplish Aim 2 by: 1) Ensuring compliance with NIH policies concerning finances, human
subjects, and data sharing, 2), Overseeing the utilization of funds and resource allocation through
management of budgets and personnel as well as logistical support of Core activities; and 3) Tracking
and reporting accomplishments and coordinating with other centers, NIA, and all relevant audiences to
maximize impact of HEADS.